PDL MSL 109 IN INFANTS WITH NON CNS SYMPTOMATIC CONGENITAL CMV INFECTIONS

This protocol is designed to evaluate the safety, tolerance and potential efficacy of at least three (and possibly four) dosages (1.0, 5.0 and 25.0 mg/kg plus possibly and intermediate dose between either 1.0 and 5.0mg/kg or 5.0 and 25.0 mg/kg) of a human anticytomegalovirus monoclonal antibody, PDL MSL-109, in the treatment of neonates with congenital cytomegalovirus infection.